A clinical trial to evaluate the impact of broadly neutralizing antibody VRC01 on HIV viral reservoir and maintenance of suppression in a cohort of early-treated children in Botswana

Abstract
Long-term viral suppression with antiretroviral treatment (ART) is difficult to maintain over the course of an
entire lifetime, and significant toxicities to ART may accumulate with time. Novel strategies that maintain HIV
viral suppression while allowing time off 3-drug ART are needed, and proof-of-concept studies to demonstrate
the feasibility of such a strategy – and to study its impact on viral reservoir, immune responses, and clinical
outcomes – are of high priority. We propose an open-label Phase 1/2 study to evaluate the efficacy of the
broadly neutralizing HIV-1 monoclonal antibody VRC01 to maintain viral suppression in the absence of ART
among virally suppressed HIV-infected children who started standard ART within 96 hours of birth (or soon
after intrapartum infection). All children will be recruited from the Early Infant Treatment (EIT) study
(U01AI114235), and have been followed from birth with frequent assessments of their clinical, virologic and
immunologic characteristics. Children who have received 96-240 weeks of ART and meet virologic entry
criteria will be offered enrollment into the proposed study. The intervention will consist of ongoing ART plus
infusions of VRC01 antibodies for a period of 6 weeks, followed by monthly maintenance administration of
VRC01 treatment alone for up to 24 additional weeks. Children receiving VRC01 maintenance therapy will be
monitored closely, with immediate re-initiation of ART following any VL > 400 copies/mL. All participants will
resume ART at week 30. The study is designed to evaluate three possible benefits of VCR01 therapy in HIV-1-
infected children: 1) we will characterize the duration of virologic control that can be maintained with VRC01
treatment following early ART, providing proof-of-concept that VRC01 may serve as a possible alternative to
standard ART in children with low viral reservoirs; 2) we will investigate whether VRC01 therapy is associated
with changes in the size and/or the cellular or clonal composition of residual viral reservoirs, which will be
highly informative for developing strategies to limit viral persistence and to destabilize viral reservoir
homeostasis in pediatric patients; and 3) we will evaluate whether treatment with VRC01 is associated with
qualitative or quantitative changes in innate or adaptive antiviral immune responses, and if it facilitates the
development of an antiviral immune profile that can enable spontaneous post-treatment viral control.

Public health relevance
Narrative HIV-infected children who initiate antiretroviral treatment (ART) in the first week of life may have both low viral reservoir and limited viral diversity, and therefore represent an ideal population to evaluate strategies other than ART for maintaining viral suppression. This study will determine whether the broadly neutralizing antibody VRC01 can maintain viral suppression in early-treated children for a period of 24 weeks off ART, and will characterize changes in viral reservoir and immune responses at each step of the intervention. The study will be offered to children participating in the Early Infant Treatment Study in Botswana who have received at least 96 weeks of ART.